Administrative Core

PROJECT SUMMARY/ABSTRACT: Administrative Core
The Administrative Core will support the Vanderbilt-Ingram Cancer Center (VICC) SPORE in Gastrointestinal
(GI) Cancer projects and investigators by 1) managing SPORE resources, communication and outreach, 2)
fostering the interaction among investigators, collaborators, other SPOREs (including the VICC SPORE in Breast
Cancer), the patient and advocate community, and 3) maintaining close ongoing interactions with the National
Cancer Institute Translational Research Program. This management and support will be accomplished through
a series of oversight committees and organized administrative and scientific meetings of GI SPORE
investigators, institutional representatives, and external advisors.